ADRENAL FUNCTION AND USE OF INTRALESIONAL TRIAMCINOLONE ACETONIDE 10 ML (KENALO

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The goal of this study is to determine whether or not standard of care treatment using an intralesional steroid (Kenalog-10) in patients with alopecia areata has a suppresive affect on adrenal gland function.